Novel Nutrient Functions and Sensing Mechanisms

Project Summary/Abstract
Despite its long history, the nutrient biology field is still facing a plethora of outstanding questions closely
related to human health, two of which will be explored in this proposal. First, the nutrient value of many
specific molecules in our diet, or the beneficial impact of many specific bacterial metabolites on human
physiology (as predicted by the symbiotic relationship between commensal microbes and host animals),
remain unclear. Second, whereas great advances have been made in the last decades on understanding
signaling systems that sense the levels of glucose, amino acids and other well-studied nutrients to regulate
various physiological events, the mechanisms that respond to the level of many other specific nutrients,
including certain fatty acids, nucleotide variants and micronutrients, are largely unexplored.
About 6 years ago, our lab boldly moved the major research direction to study problems related to
nutrient functions and sensing, focusing mainly on under-explored fatty acid variants, nucleotides and
bacterial metabolites, using the nematode C. elegans as the primary model with additional analysis in mice
and mammalian cells. In one aspect, we developed innovative assays to identify the unknown beneficial
impact of bacterial metabolites, including the siderophore enterobactin and bacterial cell wall components
peptidoglycan (PG), on animal development and behaviors. Under this MIRA grant, we will carry out a
thorough investigation of the newly discovered beneficial roles of PG fragments that have mainly been the
subject of immune defense studies in the past. By analyzing the structure of potent PG fragments, their
impacts on various aspects of animal physiology, and the interacting host factors, we aim to uncover the
mechanism of this fascinating new role of bacterial PG.
In the other aspect, our effort in recent years has uncovered four novel regulatory systems that sense
the deprivation of specific fatty acid and nucleotide variants to regulate developmental and behavioral
events to protect animals’ reproductive fitness. In particular, our study under the existing GM R01 grant
uncovered an intestine-initiated pathway that regulates germ cell proliferation and metabolism in response
to pyrimidine deficiency. Under this MIRA grant, we will address critical mechanistic questions surrounding
the roles of an obscure endonuclease that increases its expression in response to nucleotide imbalance and
that acts in the intestine to regulate metabolic and developmental events.
Past research in the C. elegans field has indicated that this organism is best used to make novel
discoveries that present important conceptual advances in biology. With promising preliminary data, the
projects described in this MIRA application have great potential to make paradigm-shifting discoveries that
would impact our understanding of the nutritional value of microbiota-produced molecules and the diversity
of nutrient-sensing mechanisms.

Public health relevance
Project Narrative The proposed study will take multiple genetic and biochemical approaches to tackle two novel nutrient-related problems that are related to human health. The first is to uncover the unexpected beneficial roles of metabolites from the bacterial cell wall to animal development and behaviors, as well as understand the underlying mechanism. The second is to uncover a gut-initiated pathway that senses the imbalance of nucleotides to regulate germ cell proliferation and nucleotide metabolism.